Clinical Core

Abstract
The Clinical Core serves the USC ADRC’s themes, cerebrovascular and metabolic contributions to cognitive
impairment; vascular and metabolic risk factors in cognitive decline; Alzheimer pathogenesis; and the prevention
and treatment of Alzheimer-related disorders. The Core’s three overarching objectives are to: 1) develop and
maintain a vascular risk factors cohort; 2) catalyze local, clinical and translational research, including early phase
clinical trials; 3) provide expertise in vascular disease, biomarkers, and imaging to national collaborative
initiatives. The Core addresses many important goals of the 2011 National Alzheimer Project Act (NAPA):
translational tools, infrastructure, trial design and conduct, novel drug targets, research on caregiver support,
recruitment and citizen engagement, biomarkers, health disparities, data sharing, and enabling technologies.
The Core enrolls and retains the primary ADRC cohorts, i.e., the Vascular Cohort Study, Brain Research
(autopsy) Study, and participants co-enrolled in Affiliated-Studies. The core performs standard evaluations and
diagnoses, oversees neuroimaging and blood and CSF biomarker collection. For this renewal, the core plans to
increase the vascular cohort, enrollment for autopsy, and Latinx participation; and continue to provide
infrastructure for over 25 ADRC-affiliated, independently-funded research studies including USC Investigator-
initiated NIH-funded clinical studies. The core is an integrated, collaborative team, including physicians (Lon
Schneider, Helena Chui, John Ringman, Elizabeth Joe, Sonia Pawluczyk), neuropsychologists (Lina D’Orazio,
Carol McCleary), and other investigators (Hussein Yassine, Judy Pa, Michael Harrington).
Its specific aims are to: 1) collaborate with the other ADRC cores to support the ADRC’s central theme by
recruiting and maintaining the vascular risk cohort; 2) recruit and maintain an ethnically diverse cohort focusing
on Latinx individuals and emphasizing vascular and metabolic risk, ADRC participation, and affiliated funded
studies; 3) recruit and maintain a the Brain Research Study cohort and work with other cores to share specimens;
4) perform annual NACC Uniform Data Set (UDS) evaluations, submit data to NACC, promote an integrated
national database, facilitate collaborative research and data sharing; 5) advance USC’s participation and
leadership in national collaborative studies by recruiting, retaining participants in ADRC-affiliated national and
multicenter projects; 6) enhance recruitment and promote dementia prevention efforts and translational research
opportunities in collaboration with the ORE core that particularly includes participants from Latinx and
underrepresented groups, and from the USC California-funded Alzheimer’s Disease Centers (CADC), and
Roybal Comprehensive Healthcare Clinic; and 7) support neuroimaging and biofluid biomarker studies.